STEP UP In Health-related Research

DESCRIPTION (provided by applicant): The Short Term Education Program for Undergraduate and Predoctoral students, STEP UP in Health-related Research is designed to offer research training to academically qualify underrepresented students. The research training focuses in the areas of interest to the National Heart, Lung and Blood Institute (NHLBI). The program represents an institutional initiative utilizing a well known multidisciplinary research environment at Temple University School of Medicine. The STEP UP takes advantage of the infrastructure of the existing research centers at Temple such as 1) the Sol Sherry Thrombosis Research Center which focuses on research related to platelet function, blood coagulation, neutrophil activation and fibrin formation, 2) the Cardiovascular Research Center with research related to the function of the cardiovascular system, and 3) the Temple Lung Center whose primary research focus is on pulmonary diseases such as COPD. The faculty of the program is comprised of 21 well recognized researchers at Temple. The program provides the students with: 1) direct exposure to biomedical research via hands-on experience while working on a project in the areas of hematology, cardiovascular and pulmonary research, 2) productive interaction with the mentors, postdoctoral fellows and graduate students, 3) information on biomedical careers, 4) guidance in choosing multiples pathways leading to a biomedical research career and 5) information on the health-related research network. The students will work in the laboratories of the mentors for ten weeks during the summer and will be given the opportunity to continue their training in consecutive years. The STEP UP Program will introduce the students to health-related research, scientific integrity, scientific thinking, critical evaluation and documentation, analysis of results, training in radiation and chemical safety, bloodborne pathogens, animal care, use of the medical library and GRE preparation. The students will participate in a seminar series and journal club and will present their research projects at the final seminar and at any appropriate research conference(s) of the scientific community. Specific plans will be implemented for recruitment, selection, retention, tracking and evaluation procedures. In summary, the primary objective of the STEP UP in Health- related Research is to offer a rewarding experience in the research environment to minority students in the areas of interest to the NHLBI to foster a long-term commitment to pursue a professional graduate career. PROJECT RELEVANCE There is a need for more diversity in the biomedical research community. The importance of the STEP UP in Health-related Research Program is to offer a rewarding experience to minority students to spark their interest in biomedical research careers. (End of Abstract)

Public health relevance
PROJECT RELEVANCE There is a need for more diversity in the biomedical research community. The importance of the STEP UP in Health-related Research Program is to offer a rewarding experience to minority students to spark their interest in biomedical research careers.